FRACTURE-LABEL--IDENTIFICATION AND PARTITION TRANSMEMBRANE PROTEINS

We used fracture label to examine the partition of the transmembrane proteins that bear CD4 antigens in human lymphocytes. Experiments in both capped and uncapped cells show that, on freeze-fracture, the antigens are preferentially labeled with the inner (protoplasmic) halves of the membrane. This partition illustrates the transmembrane attitude of the antigen molecules and is a probable consequence of interaction of the protein with other components of the membrane or with the cytoskeleton.